Anticarcinogenic Activity Of NSAID Mediated By TGFB GENE

Non-steroidal anti-inflammatory drugs (NSAIDs) are used for the treatment of inflammatory diseases. Recently, NSAIDs have been reported to have a chemopreventive effect on the development of human colorectal cancer. NSAIDs can inhibit COX-1 and/or COX-2 activity and thus inhibit prostaglandin synthesis. However, some reports indicate that the chemopreventive effect on colon cancer may, in part, be independent of prostaglandin inhibition could dependent on gene expression. Our goal is to identify and characterize genes that are regulated by Cox inhibitors including selective Cox inhibitors. Our first attempt to identify Cox regulated genes we used a PCR base method. Treatment of human colon cancer cells as well as breast and lung cancer cells causes the up-regulation of novel gene (NAG-1, "NSAIDs activated gene") which we have characterized as member of the TGF-b superfamily gene. The project will be performed with three main aims; 1) to further characterize the expression of NAG-1 by NSAIDs and to explore the potential down regulation by pro-inflammatory agents, 2) to investigate the transacting elements in the NAG-1 gene promoter, 3) to identify of biological function(s) of NAG-1 protein in apoptosis and inflammation using cell culture and animal models. We have also use Micro-Array technology to identify gene induced by selective Cox inhibitors and have found a number of genes induced and suppressed by Cox inhibitor. The study may provide new insights and mechanisms for the attenuation of colon cancer and anti-inflammatory activity of NSAIDs.